Instrumentation to Support the Research and Resources of the Viper Resource Center at Texas A&M University-Kingsville

Title: Instrumentation to Support the Research and Resources of the Viper Resource Center at
Texas A&M University-Kingsville
PROJECT SUMMARY:
Natural products have been a main foundation of drug design and snakes as well as other
animal venoms have a vast unexploited potential. The fields of venom and anti-venom research
are absolutely dependent on access to the reliable and reproducible venom-related resources
developed by the National Natural Toxin Research Center (NNTRC). Snake venoms have
provided molecular probes that have been used to decipher numerous complex physiological
and pathophysiological processes and have served as the starting point for the development of
several important classes of drugs. The NNTRC is in need of equipment crucial for advancing
the level of research as well as continuing to provide high-quality research resources to its
customers. The equipment and instrumentation being requested, Optima MAX-XP Tabletop
Ultracentrifuge, a NANOSIGHT NS300 Nanoparticle Tracking Analysis (NTA), and one
LabConco® lyophilizers, in the proposal are ideally suited to support and take research at the
NNTRC to the next level. The specific aims for the parent grant are to: 1) operate the National
Natural Toxins Research Center as a resource center that provides high quality venom and
products that support biological and biomedical research to national and international programs;
2) develop and expand the collection of snakes, specialized services and outreach programs to
support growth of venom related research in the U.S.; and 3) conduct a state-of-the-art applied
research program to support the development of new venom-related research services. Access
to these equipment and instruments will enable the NNTRC to fulfill its specific aims and allow
researchers to make important advances in the search for venom-derived therapeutics.
RELEVANCE:
The resources of the NNTRC have been applied to research in a wide range of disciplines
ranging from genomic and proteomic studies on venom evolution to translational research on
nociception and anti-venom therapeutics, research that has been supported by multiple NIH
I/C’s, the NSF, Dept of Defense, and national and international research agencies. In addition to
its roles as a national viper and venom resource, the instruments will provide undergraduate,
graduate and faculty from underrepresented areas with the opportunity to participate in state-of-
the-art research and further understand the mechanisms of toxins and their roles in the
pathophysiology of snake envenoming in order to design next generation therapeutics.

Public health relevance
PROJECT NARRATIVE Snake venoms are important in the discovery of therapeutics and drug development. Understanding the role that snake venom extracellular vesicles (svEVs) play in snake venom development/synthesis is essential to determine venom toxin mechanisms and synergy. The equipment being requested are suited to support the research and resources at the National Natural Toxins Research Center